STUDYING HTT PROTEIN AGGREGATION IN CELLS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Imaging the Htt protein aggregation in different cells (COS7, PC12). Studying the different aggregation varying lengths of polyglutamine in the protein. Analyze the dynamics of the process of aggregation.